Investigating abnormalities in top-down cortical processing and behavior in a model of the 22q11.2 deletion

SUMMARY
Schizophrenia is a neuropsychiatric disorder that causes cognitive deficits and impairments in basic sensory
processing. Structural and functional imaging studies in schizophrenia patients suggest that a main structural
signature of schizophrenia is reduced long-range connectivity and disconnection between brain areas, however
how such reduced connectivity affects specific circuit components and cortical function remains largely unknown.
In this project, we will combine in vivo linear probe recordings with optogenetic modulation in the visual system
of the mouse model of 22q11 deletion syndrome to study altered bottom-up and top-down modulation of sensory
processing. In addition, recent transcriptomics studies have found that neurogliaform cells, a distinct class of
GABAergic inhibitory neurons, are the most affected class of neurons in schizophrenia. Neurogliaform cells
primarily reside in superficial layer 1 of the cortex and receive inputs from corticocortical axons, including
prefrontal cortical regions, from the thalamus and higher-order thalamic nuclei, and from subcortical
neuromodulatory populations, however the in vivo function of neurogliaform cells in health and their dysfunction
disease remains largely unknown due to lack of tools to specifically target them. To clarify the role of
neurogliaform cells in bottom-up and top-down processing, we will manipulate activity in neurogliaform cells
optogenetically in wild type and 22q11.2 mice and measure their effect on sensory processing. The research
proposed in this application is conceptually innovative and significant because it will give us a better
understanding of how bottom-up and top-down cortical processing and neural circuits involved in schizophrenia.
This work is also technically innovative because of the novel approaches to specifically target neurogliaform cells
and investigating their role in sensory processing in health and in the context of 22q11.2. Ultimately, such
knowledge has the potential to offer new opportunities for identification of biomarkers of disease and for
therapeutic interventions that target specific circuits.

Public health relevance
PROJECT NARRATIVE Extensive evidence in humans and animal models suggest that reduced long-range connectivity and disconnection between brain areas are signatures of schizophrenia. However little is about how such reduced connectivity affects specific circuit components and cortical function. The overall goal of this project is to determine how altered bottom-up and top-down connectivity in schizophrenia impacts sensory processing, and unveil the role of neurogliaform cells, a GABAergic cell type highly affected in schizophrenia, in bottom-up and top-down sensory processing in health and in the context of schizophrenia. Ultimately, such knowledge has the potential to offer new opportunities for identification of biomarkers of disease and for therapeutic interventions that target specific circuits.